Investigating protective adaptive immune responses to influenza antigens using human tonsil organoids

PROJECT SUMMARY/ABSTRACT
Influenza virus infections cause significant global morbidity and mortality and pose a serious pandemic risk due
to the virus’s propensity for reassortment and mutation. Current influenza vaccines elicit strain-specific
responses and are only 10-60% effective depending on the year. There is an urgent need for a universal
influenza vaccine that elicits robust, persistent, and broadly cross-reactive B and T cell responses. Designing
such a vaccine will require a comprehensive understanding of how features from both the host and the antigen
modulate the magnitude, quality, and breadth of the influenza-specific response. Most human influenza studies
have been limited to peripheral blood sampling, even though the critical cellular decisions that lead to productive
adaptive immune responses occur within lymphoid tissues. Our long-term goal is to define the dynamics of the
lymphoid tissue microenvironment, including cell-cell interactions and signaling pathways, that elicit protective
immune responses in humans. Our central hypothesis is that immune signatures from mucosal lymphoid tissue
are significantly more informative than peripheral blood in developing immunization strategies that elicit robust
and broadly cross-reactive influenza responses. To address this question, we propose to leverage a high
throughput in vitro organoid platform derived from primary human tonsil tissues. Tonsils are considered both
lymphoid and mucosal tissues; they are also accessible from otherwise-healthy patients undergoing
tonsillectomy for hypertrophy or obstructive sleep apnea. Participants are demographically diverse and cover
the full human age span; males and females are represented at similar proportions. Immune organoids derived
from tonsils accurately model human germinal center responses, specific antibody secretion, and T cell activation
in response to influenza antigens. They are also able to capture host-mediated inter-individual immune variation
related to patient age, sex, and immune history. Furthermore, tonsil organoids can be used to track the kinetics
of the adaptive immune response and enable the mechanistic insights needed to rationally design a universal
influenza vaccine. The goal of this application is to understand how host features and influenza antigen features
contribute to both the magnitude and quality of the influenza immune response in humans. This proposal is
supported by strong preliminary data and if successful, will open new areas of investigation for universal influenza
vaccine development by identifying correlates and predictors of protection. We will combine comprehensive
phenotyping and mechanistic experimental approaches to define the key drivers within human lymphoid tissues
that lead to narrow, strain-specific responses. The novelty of this application lies in the systems immunology
approach that integrates demographic, serological, phenotypic, functional, and repertoire readouts in a well-
controlled immune organoid platform. Completion of the proposed experiments will help us rapidly identify
correlates of protection and guide the design and testing of a broadly cross-reactive universal influenza vaccine.

Public health relevance
PROJECT NARRATIVE This study intends to use a new tonsil organoid platform to study molecular mechanisms regulating the human adaptive immune response to influenza. We will investigate how host factors and antigen factors regulate the magnitude and breadth of the influenza-specific antibody response in lymphoid tissues. This research will combine two novel technologies, immune organoids, and a high throughput antibody-detecting protein array, to elucidate the mechanisms of antibody affinity maturation and breadth in a fully human system.